Characterizing and Restoring Joint Motion in Patients with Hallux Rigidus: Human Subject Testing

PROJECT SUMMARY/ABSTRACT
The first metatarsophalangeal joint (MTPJ1) is one of the sites most often affected by osteoarthritis (OA), leading
to a condition called hallux rigidus (HR). This is very common, estimated to affect 25% of the adult population
and increasing in prevalence with age. The number of patients seen by the Veterans Health Administration (VHA)
for HR has more than doubled over the last decade. In contrast to degenerative OA at the hip and knee, which
is commonly treated with joint replacement arthroplasties, the most common surgical treatment for severe HR is
arthrodesis, which eliminates joint function. This approach does not allow modification of footwear, interferes
with some activities (e.g., yoga, Pilates) and may lead to secondary complications such as metatarsalgia and
mobility restrictions. To date, various designs for MTPJ1 arthroplasties have been proposed, but none have been
particularly successful, with high failure rates due to loosening and regular reports of implant migration. This may
be in part because of the relatively small amount of cortical bone in the metatarsal head and proximal phalangeal
regions, making it difficult to achieve adequate fixation of the prosthetic components. Development of new
implants aimed at addressing these problems has been limited by the quantitative data regarding the mechanical
environment of the MTPJ1. Similarly, due to technological limitations, there is no precise 3D kinematic data
available to describe the envelope of normal MTPJ1 function required during activities of daily living. Our recent
work has established the groundwork for a computational modeling workflow to optimize MTPJ1 implant design,
and we have had initial success generating novel, evidence-based implant concepts that emphasize strong initial
component fixation. In this project, we intend to advance this work, increasing our ability to improve MTPJ1
implant technology through computational modeling and robotic gait simulation of human cadavers. These
better-performing implants will ultimately lead to improved patient outcomes. We intend to achieve these aims
by: 1) characterizing pathological and healthy MTPJ1 function during different activities of daily living; 2) using a
cadaveric robotic gait simulator to measure the effectiveness of existing implants and our novel implants at
restoring MTPJ1 function; and 3) further refining our musculoskeletal and finite element computational models
of the MTPJ1, improving their accuracy and validating their ability to generate clinically-informative results. It is
our working hypothesis that a successful MTPJ1 implant will exhibit both strong initial component fixation and
physiologically normative joint biomechanics; presently, our preliminary design work has emphasized the former,
while [the literature on knee joint replacements supports] the latter. We believe this research has the potential to
reinvigorate the advancement of MTPJ1 arthroplasty, which at present is primarily driven by ideas rather than
data. The knowledge disseminated from this research will allow surgeons and patients to make better decisions
regarding surgical treatments for HR. Specifically, these data will help clinicians better understand the disease
process of HR and lead to more physiologic MTPJ1 replacements that will ultimately result in an improvement
in mobility and quality of life of veterans with HR. Upon completion of the proposed study, our group will have
obtained the expertise to undertake a large clinical trial investigating surgical treatment of HR with the goals of
developing a more rigorous classification of HR, and better insight into the various causes of MTPJ1 pain (e.g.,
dorsal first metatarsal osteophytes, MTPJ1 cartilage damage, or sesamoid arthropathy).

Public health relevance
PROJECT NARRATIVE Hallux rigidus (HR) is a painful form of arthritis of the great toe joint that affects nearly half of all females and over one third of all males older than 60. Within the Veterans Health Administration (VHA), over the last decade there have been nearly 90,000 inpatient or outpatient visits for HR—a 2.3-fold increase over that time. This joint bears loads greater than body weight with each step and can be very painful when it becomes stiff and arthritic. Patients often find non-surgical (e.g., footwear-based) treatments ineffective, while surgical treatments, which either increase motion of the joint (e.g., remove excess bone), restrict the joint (i.e., fuse the two bones comprising the joint), or replace the joint (i.e., implant new mating surfaces), have all been unsatisfactory. The proposed study will characterize healthy and pathologic great toe joint motion, determine the effectiveness of total joint replacements (including a new design developed by our group) at restoring normal motion, and refine our tools that inform improved design of these implants.